InVEST: Individualized Vocational and Educational Support and Training for Clinical High Risk for Psychosis (CHR-P)

Project Summary
Despite emphasis on the importance of targeting functional impairments in early psychosis treatments, there is
no current evidence-based intervention for academic functioning in the clinical high risk for psychosis (CHR-P)
stage. Functional impairments should be a key treatment priority, given evidence that functional decline begins
during the CHR-P stage, impacts treatment engagement, and may impact other symptoms. We seek to develop
“InVEST” (Individualized Vocational and Educational Support and Training), an intervention focused on
improving educational functioning in clients ages 12-18 that are exhibiting CHR-P. Conceptualized as a
component of coordinated specialty care (CSC) for youth at CHR-P, InVEST builds on prior research on
supported employment, along with real world experience helping youth at CHR-P to pursue educational/
vocational goals within a CHR-P specialty clinic. InVEST is implemented individually (in person or via
videoconference) by bachelor's level clinician “coaches” who serve as members of a CSC team. InVEST is
designed to engage the following mechanisms which are believed to interact and to negatively impact
educational and vocational functioning during the CHR-P stage: 1) executive functioning difficulties (a
cognitive mechanism), 2) stress sensitivity (an emotional mechanism), and 3) task initiation difficulties (a
behavioral mechanism). InVEST is a novel intervention for a prioritized treatment outcome (i.e., role
functioning) in a high-risk population, and is distinct from other empirically examined approaches during the
CHR-P stage, including cognitive behavioral therapy for psychosis. InVEST takes into account the diverse
needs of youth at CHR-P by 1) prioritizing client preferences in a personalized approach and 2) teaching
strategies designed to be used independently to maximize broad access. The project will test InVEST in two
phases: 1) an open trial with 8 participants, and 2) a small randomized control trial with 30 participants
comparing InVEST against a treatment as usual waitlist control. Our treatment development objectives align
with NIMH's strategic objectives 3.2 (“Develop ways to tailor existing and new interventions and to optimize
outcomes”) and 3.3 (Test interventions for effectiveness in community practice settings). As recommended, we
are specifically optimizing supported employment programs by targeting individuals earlier in their disease
progression. Furthermore, we seek to study InVEST in a real-world community practice setting. Pilot data may
support the basis for a future, larger study, adequately powered to examine efficacy of InVEST in improving
functional outcomes and to examine potential mechanisms of change. This intervention is particularly timely
during the COVID-19 pandemic, as youth at CHR-P may be particularly vulnerable to school failure and
disengagement without the structure of in-person connection with school staff for supporting learning needs.

Public health relevance
Project Narrative / Relevance to Public Health Functional (school and work) impairments are a consistent difficulty among people with psychosis and schizophrenia-spectrum disorders, and these impairments begin even for young people who are showing early signs of risk for these diagnoses. Despite recent attention to providing treatment during early signs of psychotic illnesses to decrease risk for further worsening, there is no existing intervention focused on helping with functional impairments during this at-risk stage. We believe that this functioning-focused intervention (“InVEST”), which can be delivered either in person or via telehealth videoconference, has promise in decreasing risk of functional decline for young people showing signs of risk for psychosis.